Cancer Center Administration Core

CANCER CENTER ADMINISTRATION: ABSTRACT
The University of Kansas Cancer Center (KUCC) administration office is the principal organizational
component through which the Associate Directors, Research Program Leaders and Shared Resource
Directors execute their responsibilities to Cancer Center members of a matrix consortium Cancer Center that
includes: the University of Kansas Medical Center (KUMC) campus in Kansas City, the University of Kansas in
Lawrence (KU-L) and via consortium agreement, the Stowers Institute for Medical Research (Stowers) and
Children’s Mercy Kansas City (CM). In 2020, 171 members of KUCC accounted for $9.7M of NCI funding and
a total of $57M in overall cancer-related funding, an increase of $8M since the last CCSG submission. These
members span three research programs and are supported by seven full shared resources and one developing
shared resource. The administrative office provides administrative and fiscal oversight of Cancer Center
functions across four campuses. These functions include grant development, human resources,
communications, Cancer Center Support Grant (CCSG) management, Cancer Center, Clinical Trials Office,
and shared resource financial administration, outreach and information dissemination, and information
technology.
The KUCC administrative office is led by the Associate Vice Chancellor and Associate Director for
Administration, Teresa J. Christenson, who reports directly to the Cancer Center Vice Chancellor and
Director, Roy Jensen. Christenson has organized the administrative office to efficiently facilitate and
implement the Director’s vision and support a cancer-focused culture that fosters collaboration and productivity
among Cancer Center members. The aims of Administration are to:
1. Provide direction, leadership, and cost-effective management of resources for KUCC members across four
campuses and with its consortium partners.
2. Establish, organize, and maintain consistent information and dissemination across research programs,
shared resources, oversight committees and consortium partners to ensure Cancer Center aims are met.
3. Enhance research, clinical trial, and outreach opportunities for KUCC members by facilitating collaborative,
cross-disciplinary collaborations across campuses and consortium partners.